Homologous recombination repair pathway mutations and genetic mechanisms shaping anti-tumor immunity and immunotherapy efficacy

PROJECT SUMMARY
Immune checkpoint blockade (ICB) therapies such as PD1/PD-L1-targeting antibodies activate the
immune system to help eradicate tumor cells. However, treatment response varies dramatically across patients
and cancer types. Genetic defects in DNA damage response pathways predispose to cancer and strongly
influence tumor immunity. Our long-term goal is to understand how defects in DNA repair shape immunotherapy
efficacy. A very important and commonly altered DNA repair pathway in human tumors is homologous
recombination (HR) repair. The impact of mutations in this major repair pathway on tumor immunity is poorly
understood and is an area of urgent need. Our preliminary data show that mutations in specific components of
HR are strongly associated with superior response to ICB. Specifically, we showed that BRCA2 mutations are
associated with improved survival while BRCA1 mutations are not. Syngeneic, isogenic mouse models
recapitulate these findings. The central hypothesis of this application is that inactivation of specific portions of
the HR repair pathway sensitizes tumors to ICB. Specifically, defects in the “upstream” parts of the HR pathway
have distinct consequences on tumor immunity versus those that are “downstream” (post end-resection). The
objective of this proposal is to characterize the mechanisms by which HR defects (HRD) influence ICB efficacy.
We will accomplish our objective by pursuing 3 specific aims. In Aim 1, we will elucidate the mechanisms
underlying differential immunogenicity between Brca2 and Brca1 mutant tumors in murine models. We will
evaluate whether differences in response to ICB are due to (1) differences in intracellular immunologic signaling
between upstream and downstream HR defects resulting in distinct effects on tumor immunity and (2) genetic
alterations and generation of neoantigens vary based on the type of HR DNA repair defect. We will functionally
examine cGAS/STING, the inflammasome, RIG-I and other relevant pathways, how BRCA1 and 2 inactivation
influences these processes, and how they shape the tumor microenvironment. Aim 2 will characterize how HR
repair pathway defects influence response to ICB in human tumors. We will expand our analysis to a larger
cohort of patients, and test if “upstream” and “downstream” HR defects have distinct immunologic response. We
will validate human observations by creating additional syngeneic murine models. We will use single cell
sequencing on selected cases to delineate the functional divergence of distinct parts of the HR pathway in
shaping the TME. In Aim 3, we will characterize the mechanisms of acquired resistance in HR defective tumors
that progress after treatment with ICB. Using paired sets of samples, we will perform comprehensive evaluation
of genetic and immunologic changes during acquired resistance. We will examine whether active HR deficiency
is necessary for immunologic response, which will provide insight on the necessity of intracellular innate
immunologic signaling in mediating response to therapy. We will comprehensively evaluate the TME to identify
specific immunologic mediators of resistance.

Public health relevance
PROJECT NARRATIVE This proposal focuses on elucidating the effects of homologous repair pathway mutations on tumor immunity and immunotherapy response. We propose to use a combination of animal modeling, mechanism-directed immunologic analyses, systematic large-scale genomics, and integrated immunogenomics profiling to establish a robust understanding of the effects of homologous recombination deficiency on tumor immunity. Our studies will help build a foundation for the precise and individual application of immunotherapy for cancer patients.